MicroRNA control of tumor-promoting inflammation in colon cancer

Project Summary/Abstract
The inflammatory cytokine, interleukin (IL)-17, has emerged as a major player in inflammation-associated,
spontaneous, and metastatic colorectal cancer (CRC) models, as well as human CRC. In fact, elevated IL-17
has been negatively correlated with CRC patient survival, and even linked to resistance to both chemotherapy
and targeted therapeutics. However, master regulatory mechanisms that control IL-17-IL-17R signaling in CRC
remain largely unknown. Key Findings: We recently uncovered a critical role for the microRNA, miR-146a, in
preventing colonic inflammation and associated tumorigenesis. Mice deficient in miR-146a (-/-) are highly
susceptible to both colitis-associated and spontaneous CRC, which appears to be mediated by enhanced
tumorigenic IL-17-IL17R signaling. Mechanistically, our data suggest miR-146a limits intestinal inflammation and
CRC by two interlinked mechanisms: 1) miR-146a within myeloid cells inhibits IL-17-inducing cytokines, which
restricts IL-17 production; and 2) miR-146a within intestinal epithelial cells (IECs) inhibits tumorigenic IL-17R
signaling, which restricts IL-17 responsiveness. Within myeloid cells, miR-146a binds RIPK2, an NOD2 signaling
intermediate, to limit myeloid cell-derived IL-17-inducing cytokines, such as IL-23, and restrict colonic IL-17
levels. Accordingly, myeloid cell-specific deletion of miR-146a leads to CRC susceptibility. In addition to inhibiting
IL-17, miR-146a directly limits tumorigenic IL-17R signaling within IECs by binding TRAF6. Correspondingly,
IEC-specific deletion of miR-146a also confers CRC susceptibility. Importantly, preclinical administration of miR-
146a mimic can ameliorate CRC. Finally, we show that miR-146a appears to analogously target RIPK2 and
TRAF6 in humans, including in CRC patients, suggesting miR-146a may also limit IL-17-IL-17R signaling in
humans to control CRC. Hypothesis/Goal: We will test our hypothesis that miR-146a protects against CRC by
regulating colonic inflammation and tumorigenesis in mice and humans. In Aim 1, we will leverage IEC-specific
miR-146a-/- mice, IEC progenitor-specific miR-146a-/- mice, ApcMin/+miR-146a-/- mice, ApcMin/+miR-146a-/-KrasLSL-
G12D mice, miR-146a-silenced/overexpressing human IECs, and CRC patient samples to test if miR-146a within
IECs targets TRAF6 and inhibits IL-17R-mediated tumorigenesis in mice and humans. In Aim 2, we will leverage
myeloid cell-specific miR-146a-/- mice, ApcMin/+miR-146a-/- mice and ApcMin/+miR-146a-/-KrasLSL-G12D mice, miR-
146a-silenced/overexpressing human primary myeloid cells, and CRC patient samples to test if miR-146a within
myeloid cells targets RIPK2, where it inhibits NOD2 signaling and IL-17-inducing cytokines, ultimately restricting
IL-17 production and CRC in mice and humans. In Aim 3, we will leverage inflammation-associated CRC,
spontaneous CRC, and CRC metastasis models to test if miR-146a mimic therapeutically inhibits
tumor/chemoresistance-promoting IL-17 pathways, either alone or in combination with chemotherapy. In
summary, miR-146a is of unique significance because it constitutes a single target that modulates multiple
pathways converging on tumorigenic IL-17 signaling and may offer novel therapeutic points of intervention.

Public health relevance
Narrative Colorectal cancer (CRC) remains a leading cause of cancer-related death with limited treatment options. We recently identified a major protective role for microRNA, miR-146a, in limiting multiple angles of tumorigenic IL- 17-IL-17R signaling in CRC, and in this proposal, we use in vitro and in vivo experimental models in mice and CRC patient samples to probe the molecular mechanisms by which miR-146a mediates protection against CRC and assess targets for therapeutic intervention in a range of CRC models, including miR-146a mimic overexpression and miR-146a mimic in combination with chemotherapy. Elucidating the mechanisms by which miR-146a limits CRC may reveal novel targets for therapeutic intervention.